Regulation of MHC Class II Trafficking in Antigen Presenting Cells

MHC class II (MHC II) molecules associate with a chaperone protein termed the Invariant chain (Ii) that facilitates the transport of newly synthesized MHC-II to endo/lysosomal antigen processing compartments. Expression of Ii is required for APCs to stimulate most, but certainly not all, antigen-specific T cells. It is thought that these Ii-independent antigens are presented by pre-existing peptide-loaded MHC-II (pMHC-II) that internalize from the plasma membrane, enter into endosomal compartments, exchange old peptides for new antigenic peptides, and then recycle back to the plasma membrane for presentation to CD4 T cells. Unlike Ii-associated MHC-II, pre-existing pMHC-II on the plasma membrane rapidly internalizes into APCs and is returned to the plasma membrane following an Arf6, Rab35, and EHD1-dependent recycling pathway. We have found that the recycling of MHC-II is inhibited by ubiquitination by the March-I E3 ubiquitin ligase in immature DCs and we are following up on this observation by attempting to regulate MHC-II recycling in a variety of antigen presenting cell types to examine the importance of this post-translational modification on MHC-II function. In most APCs, the endo/lysosomal antigen processing compartments have properties of multivesicular bodies (MVBs). MVBs are formed by the invagination of the limiting membrane of the organelle, giving rise to a 500 nm structure filled with 50-100 nm vesicles. Curiously, MHC-II is present primarily on the intralumenal vesicles of MVB and it is thought that the sorting of MHC-II into these intralumenal vesicles is essential for proper MHC-II-peptide loading. The sorting signals that direct MHC-II onto the intralumenal vesicles of MVB have not been identified, and we will identify these signals and determine the extent to which specific recognition proteins (such as ESCRT), lipids (such as cholesterol or lysobisphosphatidic acid, LBPA), or post-translational modifications of MHC-II (such as ubiquitination) regulate MHC-II entry and/or exit from these compartments for antigen loading. MHC-II molecules bind antigenic peptides derived from internalized protein antigens, and any defect in antigen internalization can adversely affect the ability of APCs to function as stimulators of immunity. We have found that migratory dendritic cells (DCs) from tumor-draining lymph nodes in tumor-bearing mice are defective in soluble antigen endocytosis and are unable to effectively stimulate antigen-specific CD4 T cells. We will use tumors expressing the model antigen Ovalbumin to examine DC function and will assess the ability of these DCs to stimulate Ovalbumin-specific CD4 T cells that are necessary to stimulate anti-Ovalbumin CD8 anti-tumor responses.